Discipline D: Special Projects 1. Sample Collection

Abstract In response to the FDA's Laboratory Flexible Funding Model program announcement, the Mississippi State Chemical Laboratory (MSCL) has submitted a robust proposal titled “Enhancement of Mississippi's Capabilities in Integrated Food Safety Partnerships.” This plan encompasses six projects: • Discipline B: Chemistry, Analytical Track 1. Food Defense (Years 1-5) • Discipline B: Chemistry, Analytical Track 2. Human Food Product Testing (Years 1-5) • Discipline B: Chemistry, Analytical Track 3. Animal Food Product Testing (Years 1-5) • Discipline D: Special Projects 1. Sample Collection (Years 1-5) • Discipline D: Special Projects 2. NFSDX and ORAPP Integration (Year 1 only) • Discipline D: Special Projects 3. Method Development/Validation (Year 2 only) Surveillance sampling is an important part of a preventive approach to food/feed safety; therefore, the MSCL has proposed a thorough sampling plan for food defense, human food, and animal food product testing. Working with the Mississippi State Department of Health and Bureau of Plant Industry branch of the Mississippi Department of Agriculture, samples will be collected and analyzed for chemical contaminants.